A systems-level approach to therapeutically target STING in cancer

PROJECT SUMMARY
Most proteins have more than one function and participate in a wide range of biological processes. This compli-
cates our ability to infer protein function from sequence. This problem, otherwise known as genotype-to-pheno-
type mapping, represents one of biology’s most intractable challenges. One way by which proteins diversify their
functionality is through the evolution of modular domains, each of which can engage in distinct functions. Satu-
ration mutagenesis, which systematically alters each amino acid in a given protein, is a powerful technique to
map diverse functions to individual domains by generating separation-of-function mutants. However, the utility
of this approach remains severely limited by excessive labor, prohibitive costs, and, most importantly, low-di-
mensional readouts. The vast majority of saturation mutagenesis libraries have thus far been screened in vitro
using biochemical or simple cellular assays. There are currently no approaches to probe the complex cellular
and in vivo functions of saturation mutagenesis libraries at scale. This inspired our development of SatSeq – a
modular breakthrough technology that couples the power of single cell sequencing with saturation mutagenesis
and DNA barcoding – to map the structure-function landscape of multimodal proteins in complex and dynamic
biological systems both in vivo and in vitro. As a proof of principle, we will develop SatSeq to interrogate the
opposing functions of an immune-related protein called Stimulator of Interferon Genes (STING) in cancer pro-
gression. STING is a master regulator of innate immunity, and it has been proposed to activate anti-tumor im-
mune responses early in disease progression. Yet, recent evidence suggests that its chronic activation in cancer
cells can drive metastasis. We hypothesize that this duality is achieved through distinct functional elements.
Coupling genome-wide, single cell transcriptional profiling with in vivo interrogation of saturation mutagenesis
barcodes, we will test the modular and time-dependent functions of STING during cancer progression. We will
then utilize SatSeq as a target validation platform for STING modulators in clinical development, given its ability
to readily identify resistance mutations that prevent drug-target binding without impacting target protein activity
(i.e. gatekeeper mutations). The identification of such mutations is the gold standard for validating on-target drug
effects, which will be applied here to a set of small molecule activators and inhibitors of STING. This is particularly
salient since the first STING agonist to be used in clinical trials (DMXAA) was ineffective due to its inability to
bind its target. In sum, we expect SatSeq will have significant impact at the fundamental and translational levels.
First, it will expand our understanding of STING’s diverse functions during cancer progression – revealing the
context in STING which activation vs. inhibition is therapeutically beneficial and creating new avenues for patient
selection. Second, as a high-throughput platform to validate on-target drug activity, SatSeq will determine
whether emerging STING modulators act through on-target effects and suggest mechanisms of drug action.

Public health relevance
NARRATIVE We propose the development of SatSeq, an innovative platform for emerging therapeutics that maps multimodal functions of a protein to its sequence. As a proof of principle, SatSeq will be developed to interrogate the various functions of a protein called STING during cancer progression and metastasis. We will test whether small mole- cules targeting this pathway indeed exert their effect through protein binding, and whether emerging STING agonists or antagonists more effectively interrupt STING’s contribution toward metastatic cancer progression.